Training Program in Cardiometabolic Diseases

PROJECT SUMMARY/ABSTRACT
This is the third competing renewal application for the Training Program in Cardiometabolic Diseases
(T32HL098129). Now in its 14th year of continuous funding, this application seeks support for six MD or PhD
postdoctoral research trainees, unchanged from the current cycle. The program was originally established in
2009 to provide closely mentored, multidisciplinary postdoctoral research training to highly promising
physician-scientists and PhD scientists and prepare them for careers as independent cardiovascular
investigators. Our training program was built upon a foundation of highly accomplished and experienced NIH-
funded primary faculty members with expertise that encompassed fundamental discovery science through
translational studies and clinical investigation. The curriculum includes rigorous didactics, a personalized
mentoring plan, and an intensive research experience. The training program begins with a broad-based
educational curriculum that provides all trainees with a fundamental knowledge-base that stresses research
tools and the interface between biomedical research and important manifestations of cardiovascular disease.
Based upon prior experience and career goals, trainees will then pursue more specialized coursework and
embark upon a substantial research project under the guidance of a senior Primary Mentor and mentoring
team. Reflecting growing expertise at NYU Grossman School of Medicine (NYUGSoM) and dramatic advances
in data sciences and the opportunities the discipline provides for biomedical investigation, training, and
education, for the upcoming cycle we have integrated robust training opportunities in data and implementation
sciences into our training program. We have added exceptional new faculty with expertise in these disciplines,
drawn largely from our new Division of Precision Medicine and Department of Population Health, and
incorporated robust didactic offerings, including certificate programs and degree-granting Master’s Programs in
Clinical Investigation and Biomedical Informatics. With this expansion, our Primary Mentors now number 40
faculty members drawn from multiple Divisions, Departments, Centers and Institutes. Since its inception, we
have matriculated a total of thirty trainees, including eighteen women (60%) and five trainees (17%) from
groups that are historically under-represented in biomedical investigation. The great majority hold MDs or dual-
degrees. Of the 25 graduates of this program, most (21) have primary research (15) or research-related (6)
positions, 14 have obtained subsequent grant funding and a substantial number have been retained at
NYUGSoM (13) or have been recruited to other academic centers (4). With this consistent and longstanding
track-record of success, we remain confident that support for this program will continue to produce a steady
pipeline of highly talented and motivated investigators, including individuals historically under-represented in
our field, who are committed to enhancing cardiovascular health in the United States and elsewhere.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease remains the major cause of death in the US. Through the renewal of this highly successful postdoctoral training program, we align ourselves with the stated goal of the NHLBI to “provide a sustained flow of qualified physician-scientists able to think critically and translate findings freely between the basic and clinical spheres.” We will accomplish this goal through strong mentorship by established experts in the field, specialized didactics, and intensive training through discovery, translational, clinical and data-science research projects relevant to the major manifestations of cardiovascular disease.